Microbiome-gut-brain dysfunction in prodromal and symptomatic Lewy body diseases

PROJECT SUMMARY/ABSTRACT
Cognitive decline in Lewy body dementias [Parkinson’s Disease Dementia (PDD) and Dementia with Lewy
Bodies (DLB); a category of Alzheimer’s disease and related dementias (ADRD)], causes significant functional
impairment and does not respond well to existing treatments. Perhaps the greatest challenge for developing
effective treatments is the lack of a mechanistic understanding of the key events driving pathophysiology.
Increasing evidence suggests that a perturbed gut microbiome (dysbiosis) driven by a bloom in sulfate reducing
bacteria and increased intestinal permeability may be key mechanisms driving disease pathogenesis in Lewy
body diseases. There is a need to evaluate whether these factors are present early in the disease course and
associated with known disease processes, such as midbrain degeneration and clinical outcomes. Idiopathic
REM Sleep behavior disorder (iRBD), is one of the earliest and most specific prodromal indicators of Lewy body
diseases as up to 96.6% of iRBD patients will progress to an alpha-synucleinopathy at 14 years follow up. This
population therefore provides an opportunity to conduct a novel evaluation of the presence of a bloom in
SRB/dysbiosis and increased intestinal permeability early in the disease and whether these mechanisms are
associated with known disease processes (increases in α-synuclein, midbrain degeneration and clinical
outcomes). The proposed project will conduct a prospective, cross-sectional study to test the hypothesis that
abnormal lactulose breath tests with elevated H2S concentration (as a marker of dysbiosis and a bloom of SRB
in the gut) are present at prodromal stages of the disease and associated with increases in markers of increased
intestinal permeability and microbial translocation of lipopolysaccharide (total bacterial 16S rRNA gene and
lipopolysaccharide binding protein; LBP), known disease processes (plasma concentration of α-synuclein, MRI
biomarkers of integrity of SNc and LC) and clinical outcomes. We will recruit prodromal (iRBD), symptomatic
Lewy body disease patients (PD and DLB) and HC to evaluate our hypotheses. Consistent with several
objectives outlined in PAR-22-211, the completion of the proposed project will advance our mechanistic
understanding of the effects of a boom in SRB/dysbiosis, potentially identifying targets for disease modifying
treatments. Should our results determine an important role of gut SRB bloom/dysbiosis in the pathophysiology
of Lewy body diseases, these measurements could be incorporated into routine clinical practice to screen for
emerging pathogenic processes. Notably, many potential treatments targeting the microbiome are readily
available and subsequent clinical trials can evaluate whether interventions targeting a bloom in SRB/dysbiosis
could be used to intervene before overt motor and cognitive symptoms develop.

Public health relevance
PROJECT NARRATIVE Microbiome-gut-brain dysfunction may be one of the earliest disease processes contributing to the development of Lewy body diseases. The current project will evaluate specific aspects of microbiome-gut-brain dysfunction in prodromal and symptomatic patients to identify potential early disease mechanisms. Understanding these factors can inform future treatments targeting gut-brain-dysfunction in Lewy body diseases.